Astrocyte Norrin, Norrie disease and Neurodegeneration

PROJECT SUMMARY
Astroglia are essential for the homeostasis and maintenance of the central nervous system (CNS). They
display a vast array of roles such as neurotransmitter metabolism, regulation of synaptic neurotransmitter
clearance, extracellular ion buffering, neurotrophic release, immune signaling and blood-brain-barrier
maintenance. It is not surprising that astroglia in different regions display diverse functions to maintain their
environmental niche. Historically, astroglia were placed into two groups based on their neuroanatomical
localization and morphological depictions: protoplasmic astroglia of the grey matter and fibrous astroglia of the
white matter. Recent evidence has suggested that astroglia consist of different subpopulations, similar to
neuronal functional and molecular heterogeneity. Nevertheless, there still remain large gaps in our
understanding of these different subtypes due to a lack of molecular markers to identify and study these
populations and how these different astrocytes serve to regulate neurons and their synapses. We recently
generated a novel transgenic mouse model that selectively and robustly labels a specific astroglia
subpopulation in the adult CNS and thru RNA and protein analyses, have learned that these astroglia are
highly and selectively enriched in a secreted protein, norrin. A mutated form of norrin is the cause of a rare
neurological degenerative disease, Norrie disease. Our preliminary studies strongly suggest that astroglial
norrin plays a significant role in the local formation and/or maintenance of local dendrites and spines. We have
early data to suggest that this astrocytic norrin regulates neuronal spine density and dendritic branching in
cortical layers. Furthermore, our studies suggest that this astrocyte subpopulation is dramatically affected in
amyotrophic lateral sclerosis. In collaboration with Jackson Labs, we recently generated a Norrie disease
transgenic mouse which can allow us to explore this protein function in vivo and in disease. We plan several
approaches to understand the biology of astroglial norrin and how it may alter dendrites/spines as well its
contribution to neurodegeneration in ALS and Norrie disease. We propose to: 1) Evaluate the role of cortical
astroglial Norrin in regulating neuronal dendrites and spines in vitro and in vivo. These studies will
demonstrate the role that Norrin has in regulating neurons, primarily through dendritic and synaptic
development and/or maintenance. 2) Determine whether astroglial mutant Norrin is sufficient to alter
synaptic development and/or maintenance in vivo. We have first model of Norrie disease, and will test the
hypothesis that norrin can rescue this neurodegenerative disease of astroglia. And 3) Investigate the loss of
astroglial norrin in contributing to synaptic loss and neurodegeneration in motor neuron disease
models and human ALS. These studies will evaluate the contribution of norrin to synaptic injury in several
ALS models and human ALS. Taken together, these findings set the stage to study of this newly identified
astrocyte subpopulation in both health and disease, including the potential to generate cell astrocyte-specific
therapeutics for several neurological disorders.

Public health relevance
Project Narrative: Relevance to Human Health. Understanding the biology of astroglia and how the regulate neurons and synapses provides a fundamental biology on the brain and has great applicability to human brain disease. Furthermore, several chronic neurological diseases appear to have a strong basis in astroglial dysfunction, and the studies in this grant will further our understand of the role of these cells in ALS/FTD and could provide a powerful approach to mitigate the neural injury astroglia impose on neurons. Importantly, the role of the astroglial protein, norrin could well extend to other dementias where cortical atrophy and neuronal process are damaged such as Alzheimer's disease (AD) and frontotemporal dementia (FTD). Norrie disease, a rare cognitive injury in childhood has its basis on this astroglial pathway and the studies sin this proposal will provide important understanding to its pathogenesis, as well as candidate therapies. The convergent study of actual human brain tissue and appropriate animal models provides an unprecedented approach to understand if this new astroglial disease cascade and may open opportunities for new approaches to dementia.